Traumatic Brain Injury and Vascular Disease

Objective: Traumatic brain injury (TBI) is a common cause of morbidity and mortality in the veteran population.
In the United States, there are an estimated 5.3 million people living with a TBI-related disability. TBI
commonly leads to neurocognitive deficits, however, other systemic effects have also been associated with
TBI. Cardiovascular effects include stress-related cardiomyopathy, arrhythmias, ECG repolarization changes,
and increased cardiac reactive oxygen species. These effects may be mediated by catecholamine surges,
although the mechanism(s) are unclear. In a clinical study of TBI in US veterans, TBI was strongly associated
with the severity of coronary artery calcification as measured by electron beam computed tomography,
suggesting TBI may promote processes involved in atherogenesis. Importantly, there was a marked
independent association of TBI with cardiovascular mortality with a relative risk of 2.89 compared to a non-TBI
control group, even after adjusting for typical cardiovascular risk factors. These observations indicate there
may be a chronic and potent effect of TBI on atherosclerosis. However, whether these findings represent a
direct link between TBI and systemic vascular changes or represent other confounding factors is unclear. The
goal of this application is to determine the impact of TBI on vascular disease and to uncover underlying
mechanisms responsible for these effects. Based on these results, therapeutic interventions will be tested in
attempts to block the vasculopathic effects of TBI.
Research Plan: To assess the effect of TBI in vascular disease processes, mouse models of TBI will be used
to determine the effects of brain injury on sympathetic activity, vascular function, leukocyte-endothelial
interactions and the development of atherosclerosis. Biomarkers and possible mediators will be measured
through a combination of flow cytometry, liquid chromatography with tandem mass spectrometry, ELISA’s,
magnetic resonance imaging, and histological analyses. Therapies designed to block activation of candidate
adrenergic and downstream cytokine-triggered inflammatory pathways following TBI will be tested using
relevant vascular endpoints.
Methods: The strategy to accomplish the objectives will be to use in vivo mouse models, ex vivo, and in vitro
assays to explore mediators of inflammation and vascular disease associated with TBI. Aim 1 will determine
the effect of TBI on leukocyte-endothelial interactions and vascular function in atherosclerotic-prone
mice.These endpoints will shed light on mechanisms related to the increased vascular risk associated with TBI.
Aim 2 will explore mechanism(s) by which TBI promotes atherosclerosis by characterizing inflammatory
responses, measuring catecholamines, and testing effects of adrenergic antagonists on vascular endpoints.
Aim 3 will determine the role of downstream mediators, p-selecting glyocoprotein ligand-1, interleukin-1
receptor, and neutrophil extracellular traps (NETs) on myeloid activation and atherosclerosis induced by TBI,
as these factors could serve as therapeutic targets.

Public health relevance
Traumatic brain injury (TBI) is a common cause of morbidity in the veteran population. According to the NIH Consensus Development Panel on Rehabilitation of Persons with TBI, an estimated 2.5-6.5 million Americans live with TBI-related disabilities. The long term consequences of TBI may extend beyond the associated neuro- cognitive deficits as recent studies have indicated that the risk of cardiovascular mortality is markedly increased in subjects with a history of TBI. This mortality risk is associated with increased plaque build-up in the arteries suggesting that TBI promotes atherosclerosis. However, the causal relationship between TBI and vascular disease is not clear. If there is a causal relationship between TBI and vascular disease, this will have immediate implications for preventive therapies. The goal of this proposal is to validate the causal relationship and mechanisms involved in vascular disease associated with TBI. Potential therapies will also be tested. Results of these studies may lead to novel strategies to reduce vascular events in subjects with TBI.